Program Administration

All projects and cores in the Program Project will be supported by the Administrative Core. Dr. Bers will serve as Administrative Core Leader and will work with the Program Project Executive Committee and the Internal and External Advisory Boards to provide oversight for the coordination and reporting activities of this Core. Ms. Maureen Ramirez, Grants Administrator for the Pharmacology Department at UC Davis, will work directly with Dr. Bers and have responsibility for fiscal management of the budgets and budget reporting. She will serve as liaison for financial aspects of the subcontracts with UCSD, Rush University, Loyola University Chicago, University of Cincinnati and University of Alabama, Birmingham. With the assistance of Ms. Anita Singh (Pharmacology Department administrator) the Administrative Core will provide monthly financial status reports to project and core leaders. This core (including Ken Ginsburg, Ph.D.) will have the responsibility of organizing regular meetings for project and core leaders and will be responsible for the planning of annual workshops which will include all Program Project research personnel and members of the External Advisory Board. Travel costs for the External advisors to attend these annual meetings at UC Davis are centralized in this core. The cost of travel for grant personnel to attend two group meetings per year (one in Davis and one in San Diego) are also centralized in this Administrative Core. This core will also oversee all aspects of visits by consultants and seminar speakers.

Public health relevance
RELEVANCE (See instructions): (from overall Relevance) Cardiac myocyte calcium signaling is critical to the electrical activity which synchronizes the heartbeat, the contraction that pumps blood, energetic balance at the mitochondrial level, and the control of gene transcription. In heart failure or arrhythmias things go wrong in these pathways, contributing to heart malfunction. Here we will provide novel experimental results in careful quantitative studies, which will help to understand the fundamental workings of these systems critical to health and cardiac disease.